Examining the Role of RNF168 Activity in BRCA1 Mutant Cancers

PROJECT SUMMARY/ABSTRACT
My career goal is to develop an independent research program focused on DNA damage signaling and how it
can be exploited for the treatment of cancer. The work that I propose here explores DNA damage signaling
mechanisms in BRCA1 mutant cancers and the implications for PARP inhibitor response. Pathogenic BRCA1
mutations increase the risk of cancer development and impair the homologous recombination (HR) DNA damage
response pathway. This HR defect confers vulnerability to DNA damaging agents, including PARP inhibitors.
PARP inhibitor efficacy is limited by the development of resistance, often caused by the restoration of HR. In
BRCA1 mutant cancers, PARP inhibitor resistance and HR activity can be promoted by expression of mutant
BRCA1 proteins. Several types of truncated hypomorphic BRCA1 proteins have been detected, though the
mechanism of localization to DNA damage and HR activity has not been established. Recently, we determined
that wild-type BRCA1 recruitment to DNA damage can proceed through RNF168-dependent and -independent
pathways involving the BRCA1 RING and BRCT domains. In preliminary data, we found that RNF168 depletion
impairs tumor growth for some, but not all, BRCA1 mutant cancers. Additionally, we show that some cancer cells
are entirely reliant on the RNF168 pathway for HR, whereas others rely on the reciprocal pathway. These findings
are in line with transgenic mouse studies where different Brca1 mutant alleles produced contrasting phenotypes
upon RNF168 knockout. Here, we explore the possibility that BRCA1 mutation-specific differences arise from
the capacity to recruit various hypomorphic BRCA1 proteins to DNA damage. We will use cell line, patient-
derived xenograft, and transgenic mouse model systems to address the fundamental question of how the
RNF168 pathway contributes to tumor progression, DNA repair, and PARP inhibitor response in different BRCA1
mutant backgrounds. Specifically, we hypothesize that depletion of RNF168 in cancers expressing BRCA1 RING
domain-containing hypomorphic proteins will impair tumor progression, eliminate HR activity, and restore
sensitivity to PARP inhibitors. To test this hypothesis, we developed PARP inhibitor sensitive and resistant cell
line and patient-derived xenograft models that express hypomorphic BRCA1 proteins. Additionally, we generated
isogenic expression systems as well as transgenic mice with Rnf168 and various Brca1 mutations. Using these
models, we will examine the effects of genetic depletion of RNF168 on tumorigenesis and growth, localization of
BRCA1 hypomorphs and other DNA repair proteins, and response to PARP inhibition. These studies will provide
mechanistic insight into the repair processes occurring in cancers and assess the potential efficacy of RNF168
pathway-targeted therapeutics. Moreover, funding of this proposal will help me to secure an independent
investigator position and lay the foundation for future R01 applications to build a sustainable research program
focused on DNA repair and cancer biology.

Public health relevance
PROJECT NARRATIVE Hypomorphic mutant BRCA1 proteins support DNA repair and limit the efficacy of PARP inhibitors in a subset of BRCA1 mutant cancer patients. RNF168 is a major driver of BRCA1 localization for the repair of DNA damage, however its role in BRCA1 mutant cancers is not clear. In this proposal, we explore the BRCA1 mutation-specific roles of RNF168 in cancer cell survival, DNA repair, and PARP inhibitor response while also laying the groundwork for future development of RNF168-targeted therapeutics.